Quantitative evaluation of focused ultrasound thermal therapy on immunogenic cell death in breast cancer

Triple negative breast cancer (TNBC) is resistant to conventional therapies, leading to poor disease-free
survival and high recurrence rates. However, in contrast to other breast cancers, TNBCs have more tumor
infiltrating lymphocytes making them a suitable target for immunotherapy. While immune checkpoint inhibitors
in combination with chemotherapy, radiation therapy and other immunotherapy drugs have demonstrated
clinically relevant improvements in overall response rates for TNBC patients, response is still limited to a
subset of patients. Over the past decade, immunogenic cell death (ICD) has been recognized as an imperative
step for anti-tumor immunity. ICD is a specific cell death pathway that is induced by cellular stress, resulting in
the exposure or secretion of several damage-associated molecular patterns and cytokines which facilitate the
cross-presentation of tumor antigens to CD8+ T cells. ICD induction has become an increasingly popular
treatment option for combination therapies with preclinical and clinical studies demonstrating that
chemotherapy can act as an ICD inducer for TNBCs. However, new ICD inducers are needed to combat
systemic toxicities and oncogenic side effects of chemotherapy. Focused ultrasound (FUS) is a non-toxic,
non-ionizing, readily clinically translatable option for non-invasive, targeted tumor destruction. Immunotherapy
is an emerging application of FUS, and thermal FUS has been shown to induce release of intact tumor-
associated antigens and heat-shock proteins, an indicator of ICD, in breast cancer. However, ICD induction
after thermal FUS application has not been thoroughly characterized as a function of thermal dose. This
proposal will characterize the induction of ICD after FUS thermal treatment and investigate the mounting of
adaptive immunity in a murine TNBC tumor model. Two thermal FUS mechanisms (hyperthermia and thermal
ablation) will be evaluated in two specific aims. Aim 1 will quantify ICD induction following thermal FUS with
spatial registration of multiplex immunofluorescence to the MRI-derived thermal dose biomarker. Aim 2 will
quantify the adaptive immune response following thermal focused ultrasound induced ICD. The successful
completion of the proposal will inform how thermal focused ultrasound can influence immunogenic cell death
and subsequent adaptive immunity in a murine triple negative breast cancer model. The evaluated FUS
exposures can readily be transferred to future clinical trials as the patient-specific treatment monitoring and
MRI-based thermal dose biomarker are already utilized in ongoing FUS breast cancer clinical trials.

Public health relevance
Studies have shown that non-invasive focused ultrasound thermal therapies can induce immunogenic cell death in breast cancer, although the mechanisms are not well understood. This proposal will characterize focused ultrasound thermal therapies in a breast cancer mouse tumor model by quantifying the immune response and correlating this response to a magnetic resonance image-derived thermal dose biomarker. The results obtained by this study will provide critical information that will be immediately utilized to inform future clinical trials that investigate combining MRI guided FUS with immune checkpoint inhibitors for local and systemic tumor control.